Administrative and Coordinating Core

Administrative and Coordinating Core The objectives of the Core is to coordinate the activities of all investigators involved on two projects and three cores (Biostatistics and Data Management; Translational Biology; and Mentoring), and to facilitate communication within and between the North American and Kenyan institutions and organizations in which the AOP will directly interact. The rationale for central communication and data flow into this central structure is to avoid duplication of activities and minimize the potential for miscommunication that would be expected in a cross-cultural, international partnership.

Public health relevance
Effective communication is central to every collaborative project, especially one such as this international, multidisciplinary program. This Core is critically important to the execution of the complex translational and clinical research projects involving multiple sites and diverse sources of data over a longitudinal time frame. For this reason, the presence of a staffed administrative core tasked with efficiently coordinating the flow of data and communication between Project Leaders and Core Directors is essential for completion of this proposal.